Postcensal Estimates of Populations of U.S. Counties

The Surveillance Research Program (SRP) directs the collection and analysis of pertinent data in order to answer key questions about cancer incidence, morbidity, mortality, and cancer-related health status in diverse regions and populations in the United States. As part of its mission, SRP manages the Surveillance, Epidemiology, and End Results (SEER) Program, an integrated, comprehensive, multiple population-based reporting system. SRP also provides leadership in the interpretation of cancer statistics and in developing statistical methodologies appropriate for analyzing trends and evaluating the impact of cancer control interventions as well as geographic, social, behavioral, genetic, and health care delivery factors on the cancer burden.